ASPIRE to Change: Leveraging Text Messaging Peer Support Coaching to Mitigate Hazardous Alcohol Consumption in Non-Collegiate Young Adults

PROJECT SUMMARY / ABSTRACT
Hazardous alcohol consumption remains a significant public health issue among U.S. young adults aged 18 to
25. While interventions exist for college students, non-collegiate young adults, who constitute 38% of this
demographic, are underserved. Text messaging, with its extensive reach and asynchronous communication,
emerges as a promising intervention medium. While existing text-based interventions have shown efficacy,
there's potential for enhancement by addressing influential environmental factors. Our solution, ASPIRE
(Accountability Support through Peer-Inspired Relationships and Engagement), guided by the Social Cognitive
Theory, integrates environmental factors alongside traditional cognitive and behavioral elements. A pilot trial with
non-collegiate participants from 31 US states revealed promising results: a significant reduction in binge drinking
days and related consequences after three months of exposure to ASPIRE. Our next step involves a comparative
study of ASPIRE against a Cognitive Behavioral Intervention (CBI). In a proposed assessor-blind, randomized
trial, participants will be allocated to either CBI or ASPIRE for three months. Bi-weekly text assessments will
measure drinking patterns and peer interactions. While both groups will receive regular feedback, the ASPIRE
group will gain additional support targeting positive peer influences and strategies to modify their physical
environment. Outcomes, measured using online surveys at multiple intervals, will gauge alcohol consumption
and its associated negative consequences. Additionally, GPS data will be collected periodically to analyze
patterns, such as time spent at drinking locations. Three primary objectives guide this research: 1. Assessing
ASPIRE's effectiveness in reducing hazardous alcohol consumption compared to CBI. 2.Deciphering the
mechanisms underpinning behavior change, focusing on the role of peer influence and physical environment. 3.
Identifying which subgroups benefit most from ASPIRE to enable more tailored interventions in the future. This
research aligns with NIH's priorities, especially NIAAA's strategic plans, emphasizing a broader scope of
research and evaluating innovative behavioral interventions for non-collegiate young adults.

Public health relevance
PROJECT NARRATIVE This project aims to test the efficacy of an innovative text-based intervention, ASPIRE, designed not just to address cognitive and behavioral elements but also to modify crucial environmental factors such as peers that influence drinking behaviors. Preliminary results from a pilot trial are promising, and our upcoming research aims to further test ASPIRE's effectiveness, understand the mechanisms driving behavior change, and identify which subgroups stand to benefit most, aligning with NIH's emphasis on non-colligate young adults.